PHASE III RANDOMIZED DOUBLE BLIND CONTROLLED STUDY OF HYPERIMMUNE ANTI HIVG

To find out if giving HIVIG to pregnant HIV infected women taking AZT can lower the chance for their babies to get HIV from their mothers.